Defining mechanisms for natural vision in the primate brain with machine learning

PROJECT SUMMARY. To understand vision, we must be able to explain how it works in the natural world.
Currently, while we can explain and predict how visual cortex neurons respond in limited laboratory conditions,
most predictions fail when neurons are tested with randomly selected photographs of the natural world. One
problem is that neurons in the monkey are usually tested using simple stimuli such as lines and dots, or using
photographs from limited semantically defined categories (e.g. faces, places). In order to advance our
knowledge of how neurons function with more complex visual inputs, we manipulated naturalistic images using
neural network models called generative adversarial networks (GANs). GANS are trained to parameterize
images similar to those in the natural world. We found that, when combined with evolutionary (search)
algorithms, GANs synthesized images that highly activated inferotemporal cortex (IT) neurons, recorded using
microelectrode arrays in awake behaving macaques. Neurons showed a range of response firing rates that
exceed those elicited by previous approaches.
The discovery of these highly activating images has energized a field-wide debate about how to best
describe the tuning of neurons of the object-recognition system. Should neuronal activity be described using
investigator-designed parametric frameworks (e.g., orientation, curvature), perceptual distances from highly
activating images, or through data-fitted neural networks? In this proposed research, we will test these and
other experimental designs to determine the best way to predict neuronal responses to natural images. We will
pair approaches in a “tournament”-like meta-design, testing the same populations of neurons over hours and
across days, using chronically implanted microelectrode arrays in awake, behaving non-human primates. We
will also show which methods are best at predicting population response patterns comprising dozens of cortical
visual sites. The project will include the development of workshops with other investigating teams in order to
develop standard terminology and desiderata in explanatory theories of visual function. Although our own
overarching theory is that the activity of a given cortical neuron represents the similarity from visual inputs to
that neuron's most highly activating image (more precisely, to the visual attributes it contains), we will rely on
neural networks as a unifying mechanism behind all approaches. The project will illustrate how to derive brain-
wide organizational principles (based on ethology and concepts from natural selection) to explain visual
recognition, and to constrain the space of neural networks that can best serve as models of the brain.
The expected outcome is a framework for understanding how occipito-temporal neurons act in
naturalistic image spaces, and how their representational capabilities inform recognition-based behaviors.
Further, we will create code repositories (https://github.com/PonceLab) to encourage others to implement all
approaches in their own research.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this proposal is to explain and predict how visual system neurons function in naturalistic settings. The proposed research is relevant to public health because understanding the brain's strategies for solving problems of visual recognition will reveal fundamental aspects of neurological function, provide a target mechanism in sensory processing disorders (e.g. cortical visual impairments), and lead to efficient visual recognition systems needed in medical imaging and bioprosthetics for the visually impaired.